Community Engagement & Outreach (CEO) Core

PROJECT SUMMARY/ABSTRACT
Research Core: Community Engagement and Outreach (CEO) Core
The Community Engagement and Outreach (CEO) Core promotes research partnerships with community
stakeholders in rural populations as a part of the Center for Rural Health Care Delivery Science. The CEO
Core is committed to practices that use community-engaged principles and will support both academic and
community research partners to learn skills and best practices. By providing rural-focused consultation and
services to Center researchers (Aim 1), the CEO Core aims to address the specific challenges associated with
health care delivery science in rural northern New England, such as aging and sparse availability of health
care. In order to strengthen the Center's capacity for utilizing community-engaged practices (Aim 2), the Core
intends to expand access to the community engagement curriculum for researchers, develop a virtual rural
health community platform to improve engagement and outreach, and develop toolkits to support best
practices across all phases of research. This Core will be advised by a CEO Advisory Board comprised of
northern New England community members. In order to guide the Center's leadership and Steering
Committees (Aim 3), the CEO Core will inform the Center on the health priorities of northern New England
communities through CEO Advisory Board engagement, use of regional health needs assessments, and
partnership with the Dartmouth CO-OP Practice-Based Research Network. The CEO Core will strengthen the
overall impact of delivery science research conducted by the Center and support its mission to train a critical
mass of early-career clinician-scientists as they transition to independent research careers.